Admin Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
We propose to create a multi-institutional CHANNELOPATHY-ASSOCIATED EPILEPSY RESEARCH
CENTER that will combine high-throughput technologies for functional evaluation of epilepsy-associated ion
channel gene variants with high-content human neuron and animal model systems. The Center will be
comprised of an integrated set of 3 research projects and 2 scientific cores involving a synergistic mixture of
academic and industry scientists. Specifically, our Center will involve the efforts of more than 20 scientists and
physicians affiliated with 5 academic medical centers, 3 free standing research hospitals, and 2 industry
partners working together to investigate the functional consequences of variants in voltage-gated ion channel
genes that are the most frequently discovered cause of genetic epilepsy. The research will be interdisciplinary
and multi-faceted involving novel technologies and unique resources. The assembled investigative team is
collegial and collaborative and this will contribute to the overall success.
The Administrative Core will be responsible for managing and coordinating all major activities of the Center in
the most efficient and cost effective manner to accomplish our major goals and to achieve milestones. This
administrative oversight will involve coordination of all research components of the Center, communication
among all participants, and engagement of other stakeholders from various professional and non-professional
community partners. The aims of the Administrative core are: 1) to manage and coordinate all administrative
and collaborative activities of the Center; 2) to facilitate communication across participating institutions and
community partners; and 3) to enable public awareness of Center activities and ensure resource sharing.